Examining the Role of Social Connection in Suicide Risk for Older Autistic Adults: A Mixed Methods Study

PROJECT SUMMARY
Suicide is one of the leading causes of premature death for autistic adults. Autistic adults are more likely to
consider, attempt, and die by suicide than non-autistic adults. Understanding suicidal thoughts and behaviors
(STB) in autism is a top research priority for autistic individuals, funders, the Interagency Autism Coordinating
Committee (IACC), and autism scientific journals. Despite the increased risk, little is known about factors that
predict STB in autistic people. In the general population, older adults have the highest rates of suicide relative to
all other age groups. Social disconnection is a well-established risk factor for STB in older adults. To date, no
study has extended this association to older autistic adults.
Older autistic adults are a growing population and their needs have been highlighted as an urgent research
priority. The greater social isolation observed in older non-autistic adults is likely mirrored and potentially
exacerbated in autism: autistic adults, across the lifespan, report feeling socially isolated and lonely. Given
increased rates of STB and death by suicide in autism and the increased rates of suicide observed with older
age in the general population, older autistic adults may be doubly vulnerable to the associations between social
isolation and STB.
In response to RFA-MH-22-136, we will employ a novel mixed-methods approach to characterize the
relationship between STB and social disconnection, across multiple dimensions (structural, functional,
qualitative), in older autistic adults (aged 55 and older). We will recruit 40 older autistic adults and 25 non-autistic
older adults, oversampling for females given reports of heightened STB in autistic females and the differential
relationship between STB and social disconnection in older non-autistic males and females. This R21 has three
aims: (1) Examine how multiple dimensions (structural, functional, qualitative) of social disconnection predict
STB in older autistic and non-autistic adults; (2) Determine how assigned sex at birth impacts the relationship
between social disconnection and STB in older autistic and non-autistic adults; and (3) Explore the relative
importance of different types of activities and social and community connections and their relation to STB using
in-depth qualitative data.
This R21 directly aligns with the goals of RFA-MH-22-126 and the focus areas of the NIMH Geriatrics and
Aging Processes Research Branch and NIMH Strategic Goals 2 and 3. Further, this R21 combines two priority
areas for autism research: understanding STB and aging in autism. Data from this project will characterize how
social disconnections across multiple dimensions serve as potential risk factors for STB in older adults and will
provide actionable areas for which we can begin to develop effective and scalable interventions for this
vulnerable population.

Public health relevance
PROJECT NARRATIVE This study combines two priority areas for autism research: suicidal thoughts and behaviors and older adults. Findings will expand the body of knowledge related to suicide prevention by improving our understanding of suicide risk in older autistic adults and by informing the development of effective and scalable interventions for this vulnerable population.